Data Integration Core

ABSTRACT
Obstructive sleep apnea (OSA) is a common chronic disorder affecting over 1 billion people worldwide.
Undiagnosed and untreated OSA is also associated with a substantial economic burden, accounting for an
estimated annual cost of $149.6 billion. Given the significant disease burden and economic costs associated
with undiagnosed and untreated OSA, a robust clinical research framework is needed to address the prevention,
diagnosis, and treatment of OSA. The P4 Medicine approach to Obstructive Sleep Apnea that drives this overall
Program Project aims to conduct scientific studies that predict who will develop the disorder, prevent OSA and
its adverse consequences, and personalize diagnoses, therapies, and clinical care. In order to study OSA
through the Project in this Program, diverse and complex data from a variety of data sources, including the
electronic health record (EHR), daily continuous positive airway pressure (CPAP) usage and adherence
information, genetics, and molecular biomarkers must be studied. To effectively answer the scientific questions
posed by each Project, we have constructed a Data Integration Core (Core C) to collect, integrate, and analyze
information derived from these varied data sources. Our team will be led by Director Dr. John Holmes, an
established medical informatician and epidemiologist with over 35 years of experience in database design and
implementation, development of information systems for clinical research, and analytic collaborations with
biostatisticians and clinical researchers. Core C will be co-led by co-Directors Dr. Danielle Mowery, a clinical
informatician with expertise in data science, machine learning, and clinical research informatics, and Dr. Diego
Mazzotti, a sleep medicine researcher with specific training in biomedical informatics. The Core C leadership
and support staff bring decades of experience in clinical research, sleep medicine, data science, informatics,
digital health, genome science, epidemiology, and biostatistics. Collectively, Core C will provide data collection
and management resources, as well as development and incorporation of cutting-edge approaches to data
integration and analysis to support all Projects. We will also implement strategies related to all stages of clinical
research data management, including clinical database mining, integration of heterogeneous data sources, and
data representation according to Findable, Accessible, Interoperable and Reusable (FAIR) principles, making all
tools and approaches open-source and available to the biomedical research community at large.

Public health relevance
PROJECT NARRATIVE This Program Project grant focused on development of a P4 Medicine Approach to Obstructive Sleep Apnea clinical care will conduct scientific studies that predict obstructive sleep apnea (OSA), prevent OSA and its adverse consequences, and personalize therapies and clinical care in OSA care diagnosis. In order to study OSA through these proposed projects, diverse and complex data including physiological, imaging, molecular, clinical, and survey data must be effectively collected, managed, integrated, and analyzed. The Data Integration Core will play a key role across all projects by developing infrastructure and implementing processes to create high quality datasets necessary to answer scientific questions posed by each project study.